Wisconsin Registry for Alzheimer's Prevention

PROJECT SUMMARY
The Wisconsin Registry for Alzheimer’s Prevention (WRAP) is a longitudinal study that follows a risk-enriched
cohort from late-midlife into old age and focuses on (1) Defining the preclinical window at the level of the
individual including the onset of Alzheimer’s disease (AD) proteinopathy and cognitive decline prior to overt
clinical symptoms; (2) gaining a comprehensive picture of the effects of nonmodifiable genetics and modifiable
health and lifestyle factors on cognitive and AD biomarker onsets and trajectories; (3) characterizing the
presence and impact of other diseases associated with cognitive decline—chiefly vascular disease. WRAP
consists of over 1,729 (1386 active) adults who enrolled in midlife (baseline mean age 54 yrs), are followed
biannually for an average of 12 years of follow-up so far, and on whom we conduct cognitive, lifestyle, lab,
medical and biomarker assessments of AD and related disorders (ADRD). In the prior cycle we: (i) Developed
methods for identifying subtle cognitive decline utilizing each participant’s own baseline performance, thereby
improving sensitivity to decline while reducing diagnostic bias; (ii) Derived temporal information from amyloid
positron emission tomography (PET) and plasma assays showing that amyloid onset age can be estimated and
precedes tauopathy, (iii) found that when amyloid and tau proteinopathies are present, cognitive decline
accelerates; (iv) showed that lifestyle and health factors affect cognitive decline and likely impact the length of
the preclinical window; (v) showed that AD pathology/risk and aspects of vascular changes/risk independently
and jointly impact brain health and cognitive decline; (vi) included WRAP data in several multi-cohort
collaborations that have advanced the field. With these gains and new supportive preliminary data, WRAP is
uniquely positioned to address the following major aims and knowledge gaps in the next cycle: Aim 1 will derive
person-level estimates of the preclinical window defined as the interval between onset of AD proteinopathy and
the onset of cognitive decline. We will perform 3000 main WRAP study visits from which we will characterize
cognitive decline. We will assay 4,400 existing and 2,640 anticipated plasma samples for AD-related biomarkers.
Subsets undergo AD (PET and/or CSF) and vascular (MRI and ultrasound) biomarkers. PET—plasma
concordances will be established, and analyses using plasma-derived ADRD biomarkers will be conducted on
the entire cohort. Aim 2 examines relationships between key genetic and health/lifestyle predictors to cognitive
decline in the context of AD biomarkers. Aim 3 examines the inter-relationship between cerebrovascular health
spectrum and its associations with cognitive decline relative to AD proteinopathy. Overall, the questions that
WRAP is addressing with its longitudinal assessments and advanced temporal modeling are innovative and vital
to the field regarding defining preclinical AD with greater precision at the level of the individual, and determining
the factors that modify this window.

Public health relevance
NARRATIVE Alzheimer’s disease (AD) represents a major social and public health problem which will worsen as our population ages. This longitudinal observational cohort study is describing the timecourse of presymptomatic proteinopathy and cognitive decline and the influence of risk factors. Discoveries will inform early detection, prognosis planning, and interventions that delay or slow the progression of the disease.